CARDIOVASCULAR DISEASE IN DIABETIC PATIENTS WITH AUTONOMIC NEUROPATHY

This study will examine whether patients with diabetes mellitus and autonomic neuropathy are more prone to developing arrhythmias than those without. Diabetics with automatic neuropathy, based on R-R variation, response to valsalva, postural changes and isometric exercise will be compared to those without neuropathy.